Assessing a Novel Paradigm of Inducing Cryotolerance

DESCRIPTION (provided by applicant):The practical goals of this study will be the development and optimization of a serum free cryoprotection medium with minimum levels of cryoprotectants. We intend to pursue these studies using a hypothesis-driven, mechanism-based experimental approach, i.e., the viability of the cryopreserved adult stem cells (ASCs), in the undifferentiated, adipocyte- or osteoblast- differentiated states, can be improved by increasing the pre-freeze expression of heat shock proteins (HSPs). PUBLIC HEALTH RELEVANCE: This proposal will determine the link between the expression of heat shock proteins and pre-freeze (control) and post-freeze (cryopreservation) potential (osteogenic and adipogenic) of human adipose tissue derived adult stem cells (ASCs).

Public health relevance
This proposal will determine the link between the expression of heat shock proteins and pre-freeze (control) and post-freeze (cryopreservation) potential (osteogenic and adipogenic) of human adipose tissue derived adult stem cells (ASCs).